Targeted degradation of KRAS oncoproteins triggers antitumor immunity and abolishes lung tumor

Summary: Non-small cell lung cancer (NSCLC) is one of the leading causes of cancer death worldwide. KRAS
is the most frequently mutated oncogene in lung adenocarcinoma, the most common subtype of NSCLC.
Approximately 30% of patients with lung adenocarcinoma harbor KRAS mutations, with G12C and G12V being
the most frequent forms. Direct targeting KRAS was historically difficult until the recent development of KRAS
G12C specific inhibitors, including AMG510 and MRTX849. These inhibitors have shown strong anti-tumor
effects in KRAS G12C-mutated lung adenocarcinoma patients, exemplified by the recent FDA approval of
AMG510 (Sotorasib). Despite this breakthrough in KRAS therapeutics, Sotorasib demonstrates a 32% response
rate in patients with lung cancer and patients often develop rapid resistance. Furthermore, there are no specific
inhibitors for KRAS G12V, the second most common KRAS mutation in NSCLC. Therefore, there is an urgent
need to develop new strategies to improve the clinical response to KRAS G12C inhibitors, as well as to tackle
KRAS G12V lung adenocarcinoma. PROteolysis TArgeting Chimeras (PROTACs)-mediated protein degradation
has emerged as a powerful system to specifically target oncogenic drivers. Utilizing this PROTACs system, we
have developed a versatile approach known as the degradation tag (dTAG) system, to rapidly deplete any tagged
target protein in vitro and in vivo. Our preliminary study demonstrated that dTAG potently degrades oncogenic
KRAS variants and abolishes lung tumors in vivo, and drives anti-tumor immunity through increasing CD8+ T
and dendritic cell activity. My proposed project will leverage the dTAG system and novel KRAS G12C and G12V
preclinical models (organoids and genetically engineered mouse models (GEMMs)) to further evaluate KRAS
degradation as a new therapeutic approach. Furthermore, with the KRAS G12C inhibitors and immunotherapy
clinical trials underway, evaluating the in vivo therapeutics of combining KRAS degradation with immunotherapy
is of high significance. Overall, Aim 1 is to comprehensively evaluate efficacy of targeted degradation of
oncogenic KRAS variants alone and in combination with immunotherapy in vivo. Aim 2 will dissect tumor
microenvironment alterations upon degradation of oncogenic KRAS mutants alone and in combination with
immunotherapy. Aim 3 will characterize the underlying cancer intrinsic and immunological mechanisms that
contribute to antitumor immunity. Findings from my research will offer evidence for further evaluation of the
protein degradation in targeting KRAS mutant cancers in clinical trials.To achieve these aims, I designed a 3-
year plan that includes participation in scientific and career development meetings, workshops and coursework
to further develop my cancer immunology and computational biology expertise. This career transition award will
greatly facilitate my goal of leading a multidisciplinary research laboratory focused on addressing challenges in
the treatment of lung cancer in the academic environment of an NCI-designated comprehensive cancer center.

Public health relevance
Narrative Non-small cell lung cancer (NSCLC) is one of the leading causes of cancer death worldwide, with KRAS being the most frequently mutated “driver” gene. Utilizing a state-of-the-art preclinical platform, this proposal aims to explore the therapeutic potential of targeted degradation of KRAS oncoproteins alone and in combination of immunotherapy in NSCLC, and dissect the underlying mechanisms associated with antitumor immunity.